MAD EXPERIMENT ON COILED COIL OLIGOMERIZATION SWITCH

We wish to understand the origins of structural specificity and molecular recognition in proteins. In the dimerization domain of the yeast transcription factor GCN4, apolar mutants of a conserved, buried Asn16 side chain allow the domain to form a mixture of dimeric and trimeric coiled coils. This induced structural polymorphism provides a unique opportunity to study the impact of core packing on structural uniqueness. The N16A mutant of GCN4 forms a mixture of dimers and trimers under physiological conditions, but addition of small amounts of benzene results in trimers. The crystal structure of this benzene-induced trimer reveals a benzene molecule bound in the cavity normally occupied by position 16's side chains in other GCN4 mutant trimers. To understand how a hydrophobic molecule can restore structural specificity to a coiled coil, we must examine the packing in both oligomeric states and solve the structure of the N16A dimer.